Targeting IDOL-ApoE receptor pathway in Alzheimer's disease

Apolipoprotein E (APOE) genotype strongly impacts several major pathological features of
Alzheimer’s disease (AD), including extracellular β-amyloid (Aβ) deposits, intracellular tau
tangle formation, and microglial dysfunction. The metabolism and signaling of ApoE in the brain
are controlled by members of the lipoprotein receptor superfamily, and genetic manipulation of
ApoE receptors has been shown to significantly impact AD pathology. Hence, the pathways
modulating ApoE receptors in the brain represent promising targets for the therapeutic
intervention in AD.
Previously, we have identified the inducible degrader of the LDLR (IDOL), an E3 ubiquitin
ligase, is a major post-translational regulator of three ApoE receptors: low-density lipoprotein
receptor (LDLR), very low-density lipoprotein receptor (VLDLR), and ApoE Receptor 2
(ApoER2). Each of these ApoE receptor plays key role in modulating ApoE actions and
impacting AD pathogenesis in the brain. We showed that both genetic deletion and therapeutic
reduction of IDOL increases brain ApoE receptors levels, decreases Aβ levels, and improves
cognitive functions in mouse models of Aβ amyloidosis. Our recent mechanistic research
revealed IDOL knockdown markedly increases microglial phagocytosis of fibrillar Aβ in vivo, and
the subpopulation of disease-associated microglia (DAM), a phagocytic microglia population
associated with Aβ plaques. Our research also suggests that LDLR, an IDOL substrate, plays
an important role in facilitating metabolic reprogramming of microglia during phagocytosis likely
by mediating the uptake of ApoE lipoproteins. Furthermore, IDOL regulates the expression of
ApoER2, a receptor that is enriched in the postsynaptic membrane of excitatory synapses.
ApoER2-mediated signaling is known to increase glutamatergic neurotransmission and
antagonize Aβ-induced suppression of synaptic functions. We showed that manipulation of
IDOL expression in neuron is sufficient to modulate synaptic transmission. Based on these
results, our goals of this proposal are to delineate molecular mechanisms by which IDOL-ApoE
receptor pathway modulates ApoE actions and impacts Aβ pathology. Aim 1 is to define the role
of IDOL in facilitating microglial response to Aβ and impacting the progression of Aβ pathology.
Aim 2 is to elucidate the mechanisms of how IDOL-LDLR axis facilitates metabolic
reprogramming and ApoE signaling in microglia. Aim 3 is to delineate the role of neuronal IDOL
in enhancing ApoER2-mediated signaling and protecting against Aβ-induced synaptic
dysfunction and cognitive deficit.

Public health relevance
Alzheimer's disease is a devastating neurodegenerative disorder resulting in cognitive impairment and progressive dementia, and currently no effective cure has been identified. Our proposed studies aim to understand the multifactorial role and underlying mechanisms of action of an E3 ubiquitin ligase IDOL in AD pathology. This research will have the potential to reveal a novel therapeutic target for the treatment of Alzheimer’s diseases.